Trial of Statins for Chemoprevention in Hepatocellular Carcinoma

PROJECT SUMMARY
Worldwide, hepatocellular carcinoma (HCC) represents the fifth most common cancer and the second-leading
cause of cancer-related mortality. In the U.S., both the HCC incidence and mortality are increasing at an alarming
pace. Despite these concerning trends, treatment options for HCC remain limited, and the prognosis is grim, with
a 5-year survival rate of just 15%. Thus, identifying effective strategies to prevent the development of incident
HCC represents a critical public health need. A growing body of preclinical and population-based observational
data now demonstrate that lipophilic statins, and in particular atorvastatin, reduces hepatic inflammation, cellular
proliferation and cancer cell invasion, and reduces the incidence of HCC, in part by acting on relevant pathways,
including the Hippo-YAP signaling pathway. However, despite these promising data, well-designed randomized
controlled trials (RCTs) of atorvastatin for HCC prevention have not yet been reported. Historically, the feasibility
of an HCC prevention trial has been limited by large sample size and long lengths of follow-up required to assess
target endpoints. Recently, however, our group has derived and validated a 186-gene expression Prognostic
Liver Signature (PLS), that represents an accurate, reproducible and highly reliable surrogate biomarker for HCC
risk in multiple international cohorts of all major viral and non-viral etiologies of cirrhosis. Further, we have
demonstrated that therapeutic modulation of the PLS accurately recapitulates future risk of developing incident
HCC tumors, both in vivo and in confirmatory human studies. Finally, we and others have demonstrated in human
liver tissue samples that atorvastatin modulates the PLS in part by acting on the Hippo-YAP pathway. Thus, the
PLS represents a novel and highly tractable surrogate biomarker endpoint for an RCT of atorvastatin for the
reduction of incident HCC risk.
In this proposal, we will conduct a phase II RCT in 60 patients with compensated cirrhosis, designed to test the
efficacy, safety and tolerability of 48 weeks of atorvastatin for the reduction of HCC risk, defined by our validated
PLS profile. All subjects will have a high-risk PLS defined at screening liver biopsy, and subjects will be randomly
assigned to 1 of 2 study arms for the 48-week study period: atorvastatin 20mg/day or placebo, with appropriate
monitoring for the 48-week period, followed by a repeat biopsy at week 48 to assess for improvement in the PLS
profile. We will also confirm whether atorvastatin has adequately engaged its targets by evaluating
pharmacokinetics/pharmacodynamics, pre/neoplastic markers, and alteration in the Hippo-YAP pathway. We
hypothesize that PLS-based HCC risk level decreases in the atorvastatin arm at the end of 48-week treatment.
If atorvastatin treatment is effective, safe and well-tolerated, it could become the first chemopreventive agent
designed to prevent the development of HCC, guided by PLS, in the growing population of patients in the U.S.
who are affected by cirrhosis and are at high risk for this devastating complication.

Public health relevance
Project Narrative The efficacy of existing therapies for hepatocellular carcinoma (HCC) is highly limited. Therefore, prevention of HCC development in patients at risk, i.e. liver cirrhosis, is urgently needed. Based on prior supportive data generated by us and others, we will evaluate atorvastatin in a placebo-controlled phase II clinical trial for its safety and efficacy in modulating a high-risk HCC gene signature in patients with compensated cirrhosis.